Impact of tissue resident memory T cells on the neuro-immunepathophysiology of anterior eye disease

ABSTRACT
T cells are major clinical targets for anti-inflammatory treatment of persistent ocular pain induced by anterior eye
diseases such as dry eye, yet identification of which T cell subsets drive the pathophysiology of anterior eye
disease remains a topic of intensive preclinical investigation. Emerging data shows that a relatively recently
discovered pro-inflammatory subset of T cells that rarely re-enter circulation dominate the T cell niche on the
ocular surface of humans but are almost nonexistent in preclinical models of dry eye disease. Establishment of
these tissue resident memory T cells (TRM) in the eye requires pathogen exposure or vaccination, and because
we house laboratory rodents in unnaturally clean environments, they have extremely limited exposure to
pathogens. This lack of immunologic experience has precluded the use of extant rodent models to investigate the
impact of TRM in neuro-immune mechanisms of anterior eye disease, and the potential interactions between TRM
and nociceptors in ocular inflammation and pain remains a pressing gap in knowledge. We propose to address
this gap by infecting mice with a clinically relevant ocular pathogen to establish a population of “human- like” TRM
in the eye that can be specifically targeted for activation or depletion. Using this rodent model, we will modulate
the activity/presence of TRM and/or nociceptors in the anterior eye to test the central hypothesis that TRM and
nociceptors engage in bidirectional neuro-immune interactions that cause ocular pain and inflammation.
Additionally, these animals will be used in a desiccating stress model of dry eye disease with and without
depletion of resident (TRM), and/or circulating virus-specific CD8+ memory T cells, to determine the relative
impact of these experience-dependent memory immune cell populations on dry eye pathophysiology. These
studies will gain critical insights into neuro-immune mechanisms that drive the pathophysiology of anterior eye
disease and determine how prior viral infection shapes the manifestation of subsequent neuro-inflammation.
This work will inform innovative avenues for the treatment of human ocular pain and inflammation and bear broad
impact for the field of neuro-immunology through first-ever investigation of TRM interactions with the sensory
nervous system.

Public health relevance
PROJECT NARRATIVE The prevalence of idiopathic dry eye disease is on the rise in the United States. Characterized by ocular pain and inflammation, this anterior eye disease is believed to involve dysregulation of the adaptive immune system and negatively impacts the economic productivity, quality of life, and visual acuity of those afflicted. This proposal will significantly advance our understanding of neuro-immune interactions in human dry eye by innovating a preclinical disease model to study a population of highly proinflammatory adaptive immune cells that are typically absent in laboratory mice, but which have recently been shown to dominate the ocular surface of humans. This mechanistic analysis in mice will yield data critical to the development of novel treatments for human neuro- inflammatory diseases of the anterior eye.